COMPUTER NAIL BED CAPILLAROSCOPY

The objective of this project is to construct and evaluate a dedicated computerized digital imaging system for nail bed capillaroscopy that will be useful in the clinical, research and medical education environment. This system will promote more effective use of this diagnostic test through improved imaging of the nail bed capillaries, easily obtained quantitative measurement of capillary characteristics, improved documentation of exam, enhanced capability to perform research on the technique and by providing a comprehensive educational tool to teach the technique to physicians.